BIOINFORMATICS SUPPORT FOR DNTP & DIR

The Bioinformatics support contract provides bioinformatics support for Omics technologies. Examples of projects needing support for bioinformatic analysis include toxicogenomic analysis for 1) support for circulating cell free DNA (ccfDNA); 2) support for Mouse Aging study by providing dendogram and SNP analysis for 10 strains of mice; 3) support epigenomic analysis of DNA methylation changes in an in vitro model of cellular transformation; 4) analysis of 3D spheroids of HepaRG. Differential gene expression from TempO-Seq data performed with fold changes and pvalues; 5) support provided for analysis of microarray toxicogenomic data for placenta and liver; 6) support for analysis of AFFF (aqueous film-forming foams) for comparative analysis of toxicity after in vitro exposures in HTT assays.